Investigating folliculin as a regulator of VLDL-TG secretion in non-alcoholic fatty liver disease and steatohepatitis

Abstract
Non-alcoholic fatty liver disease (NAFLD) is a rapidly emerging public health risk. Approximately 35% of
Americans have NAFLD, and if left untreated, NAFLD can progress to non-alcoholic steatohepatitis (NASH),
cirrhosis, and hepatocellular carcinoma. Although obesity and Type II diabetes have emerged as risk factors,
disease pathogenesis is poorly understood. Accordingly, there are no FDA-approved pharmacotherapies
currently available for patients with NAFLD/NASH. An ideal therapeutic would target multiple hepatic lipid
homeostatic processes, including de novo lipogenesis (DNL), fatty acid oxidation (FAO), and very-low-density
lipoprotein (VLDL)-triglyceride (TG) secretion, as attempts to modulate a single lipid homeostatic process have
often led to undesirable compensation from the remaining pathways. Our lab has identified the protein folliculin
(FLCN) as a potential therapeutic target. Mice with hepatic deletion of FLCN are robustly protected against
steatosis when challenged with NAFLD-inducing diets via an FLCN-mTORC1-TFE3 signaling axis. TFE3
suppresses DNL and induces genes involved in FAO to decrease hepatic TG content in FLCN-null livers. Given
that VLDL-TG secretion is heavily regulated by TG availability, we expected to see a compensatory decrease in
VLDL-TG secretion rate in FLCN-null mice. Strikingly, however, we saw marked upregulation of VLDL-TG
secretion in FLCN deficient mice, which makes FLCN even more appealing as a therapeutic target. I hypothesize
that upregulated VLDL-TG secretion is critical to the robust protection against steatosis afforded by liver deletion
of FLCN, and that activated TFE3 is necessary and sufficient for VLDL-TG secretion. To test this, I will generate
FLCN knockout (KO), TFE3 KO, and FLCN/TFE3 double knockout (DKO) mice and assess VLDL-TG secretion
rates. I will overexpress constitutively active TFE3 in wild-type mice to test if TFE3 is sufficient for VLDL-TG
secretion. My preliminary data further lead me to hypothesize that the upregulated VLDL-TG secretion in FLCN-
null livers is mediated by TFE3-dependent transcriptional activation of CTP:phosphocholine cytidylyltransferase
alpha (CCTa). CCTa is the rate-limiting enzyme in the synthesis of phosphatidylcholine, a critical necessary
component for VLDL-TG secretion. My preliminary data show increased CCTa mRNA and protein levels in FLCN
knockout mice. I will generate FLCN KO, CCTa KO, FLCN/CCTa DKO mice. I will assess their susceptibility to
NAFLD/NASH and perform VLDL-TG secretion assays. Completion of this work would provide insight into the
regulation of hepatic lipid homeostatic processes affected in NAFLD/NASH, as well as demonstrate FLCN to be
a promising therapeutic target for treatment.

Public health relevance
Project narrative Disease pathogenesis for non-alcoholic fatty liver disease (NAFLD) and non-alcoholic steatohepatitis (NASH) remains poorly understood and attempts to modulate a singular hepatic lipid homeostatic pathway have been plagued by unexpected compensation and feedback loops. We have shown that loss of hepatic folliculin (FLCN) robustly protects against NAFLD/NASH via an FLCN-mTORC1-TFE3 signaling axis that controls de novo lipogenesis and fatty acid oxidation. We have evidence that this non-canonical mTORC1 signaling also regulates VLDL-TG secretion and we propose that upregulated VLDL-TG secretion is a major mechanism by which loss of FLCN protects against NAFLD/NASH.